A preconception cohort study of environmental chemicals, fertility, and miscarriage

ABSTRACT
Infertility and spontaneous abortion (SAB) are significant public health problems, affecting up to 25% of
reproductive age couples in the United States. Health care costs attributable to infertility and SAB exceed $5
billion per year, and several studies have shown an association between infertility treatments and adverse
pregnancy outcomes. Thus, identifying modifiable risk factors for subfertility and SAB is an important public
health goal. The potential effects of exposure to endocrine-disrupting chemicals (EDCs) on risk of subfertility and
SAB are understudied. The few existing human studies have limitations including small sample size, enrollment
after conception, retrospective study design, suboptimal assessment of exposure and outcome, inadequate
control for potential confounding variables, and limited generalizability. The proposed study will prospectively
assess the relation of exposure to selected EDCs, including phenols, phthalates, and per- and poly-fluoroalkyl
substances (PFAS), to risk of subfertility and SAB in a preconception subcohort of 950 pregnancy planners. We
will use data from two NICHD-supported prospective cohorts of pregnancy planners in North America and
Denmark. With web-based recruitment and data collection, we have enrolled over 17,000 women attempting
pregnancy into these cohorts. In a subset of 200 participants, we have successfully pilot tested in-person
collection of urine and blood specimens during the preconception and early pregnancy periods. In this
application, we propose to expand in-person biospecimen collection, increasing the number of women with
preconception and early pregnancy urine and blood samples from 200 to 950. At each of our three biospecimen
collection sites (Boston, Detroit, and Aarhus), we will enroll 250 women and collect three urine samples and one
blood sample (in preconception) and three urine samples and one blood sample (in early pregnancy). We will
ship the samples to the CDC for the analysis of urinary phthalates, urinary phenols, and serum PFAS. To
increase cost efficiency, we will pool three urine samples in each exposure window before assaying for
phthalates and phenols; and we will assay one preconception blood specimen for PFAS, a persistent chemical,
in analyses of subfertility and SAB. Finally, we will conduct a pilot study among 100 U.S. participants to assess
the feasibility of collecting urine by mail, which would allow us to take advantage of our full geographically-diverse
cohort in the future. Strengths of this application include the prospective design, preconception enrollment of
pregnancy planners, repeated measurement of exposure during preconception and early pregnancy, excellent
control for confounding via bimonthly prospective data collection on a wide range of covariates, and use of the
latest analytic methods for mixtures modeling. We have generated compelling preliminary data to support our
aims. The present grant is cost-effective in leveraging already-established cohort studies with data collection
and follow-up supported by other grants. The results generated will be translatable by directly informing future
regulatory decisions about EDC standards in a manner that could reduce rates of infertility and SAB.

Public health relevance
PROJECT NARRATIVE Nearly 15% of all couples have difficulty becoming pregnant and up to 25% of all pregnancies end in miscarriage. Infertility and miscarriage can cause profound psychological and financial hardship for those affected, and they account for more than 5 billion dollars in U.S. health care costs each year. Identifying modifiable risk factors for infertility and miscarriage, including environmental pollutants (phenols, phthalates, and per- and poly-fluoroalkyl substances), is an important public health goal.